Research Experience and Training Coordination Core

The Research Experience and Training Coordination Core (RETCC) of the OSU SRP will integrate with all other
components of the Center to provide trainees with intensive multidisciplinary training and professional
development. Our work will support the research, research translation, and community engagement goals of the
Center and will prepare the trainees to succeed in a broad range of careers in academia, industry, and
government. We will achieve these objectives in three Specific Aims: 1) Recruit an outstanding talented
cohort of trainees to the OSU Superfund Program, 2) Prepare a skilled workforce with the core
competencies and multidisciplinary experience necessary to solve the complex issues
associated with PAH mixtures, and 3) Monitor, evaluate and report on individual trainee
performance and the overall success of the program. As the centerpiece of our training program, we
will implement Individual Development Plans (IDPs) for pre- and postdoctoral trainees. IDPs provide the
framework for an on-going evaluation that identifies professional development and experiential training needs
in the context of required core competencies and personalized short- and long-term education and career goals.
RETCC leaders, with the Research Project and Core leaders, will help trainees to develop their IDPs, articulate
goals, identify and leverage training opportunities, and assess progress. Trainee IDPs will emphasize crosstraining
in complementary disciplines across the spectrum of Superfund-related biomedical and environmental
science and engineering research. RETCC leaders, with the Research Project and Core PI’s and a talented cohort
of constituents and collaborators, will provide a broad selection of state-of-the-art training activities, including
transdisciplinary coursework, seminars, workshops, journal clubs, experiential training, and professional
development modules. The RETCC will promote interdisciplinary training and professional development by
supporting new externships, expanding opportunities for KC Donnelley externships, and supporting traineeinitiated
collaborative pilot projects. Individual IDPs will require trainees to engage in leadership training and
leadership opportunities, to deliver presentations at local, regional and national conferences, and to participate
in activities initiated by the CEC, RTC, and DMAC. RETCC leadership will coordinate training activities, track
and collect trainee performance for CareerTrac (with a new on-line data entry portal (OSURE – OSU REports),
and evaluate not only trainee performance but also the overall success of the program. We will coordinate trainee
and Core activities and achievements with the Center and the SRP. Our training program will help the OSU SRP
to achieve its goals and will help the trainees to solve real-world environmental health problems, especially those
associated with Superfund sites, now and in the future.

Public health relevance
NARRATIVE-RESEARCH EXERIENCE AND TRAINING COORDINATION CORE The Research Experience and Training Coordination Core (RETCC) will recruit a talented cohort of trainees to the OSU Superfund Research Center, help them acquire the core competencies and multidisciplinary expertise necessary to solve the complex issues associated with PAH mixtures, and monitor, evaluate, and report on the performance of individual trainees and the overall success of the program.